INSIDE CANCER, MULTIMEDIA EDUCATION RESOURCES FOR CANCER

The Internet has seen an explosive growth in the past few years, and masses of information on cancer are readily available to anyone with a live connection. Unfortunately, the vast majority of this information is presented in long test passages, with few illustrations and non multi- media elements to increase user interest. Absent are materials that help people appreciate how basic research in cancer genetics is being rapidly translated into new options for diagnosis, treatment and prevention. We seek support to create an extensive WWW site, Inside Cancer, which literally will take people into the workings of the cancer cell and into the laboratories of scientists who are revolutionizing cancer research. Building upon the project staff's strong experience in building multimedia WWW sites, Inside Cancer will make use of the most up-to- date technology to merge animation and video into a visually stimulating experience. At the same time, the project draws scientific authority from a world-renowned research institute and advisors who have played important roles in the development of modern cancer research. Five modules will be developed. What is Cancer? quickly answers this and other related questions in short animations and prepares more curious visitors for the next modules. Cancer in the Laboratory features researchers explaining animated sequences of their own experiments, which laid the foundation for understanding cancer at the molecular level. Cancer Causes and Prevention animates the molecular events triggered by carcinogens, such as tobacco smoke and diet and emphasizes how lifestyle changes can reduce cancer risk. In Cancer Diagnosis and Treatment visitors shadow doctors making a cancer diagnosis, showing the connections between cancer cell alterations and new treatment options. Pathways to Cancer takes visitors on a 3-dimensional tour of a cell and its signaling pathways, then allows them to see downstream effects of mutations and their relation to cancer development. As new findings and therapies are discovered, we will update the modules to keep Inside Cancer current.